i-Corp -Transforming Hospitalizations of Autistic Adolescents via a Novel ABA Telehealth Platform

The I-Corps curriculum provides real-world, hands-on, immersive learning about what it takes to
successfully translate promising technologies into products or services that will benefit society. At the
beginning of the training program, all I-Corps team members are required to attend an evening reception
plus an intensive, 3-day Kick-Off Workshop (exact location to be announced).

Public health relevance
The I-Corps curriculum provides real-world, hands-on, immersive learning about what it takes to successfully translate promising technologies into products or services that will benefit society. At the beginning of the training program, all I-Corps team members are required to attend an evening reception plus an intensive, 3-day Kick-Off Workshop (exact location to be announced).